Role of GLUT1 in diabetic cardiomyopathy

ABSTRACT
Diabetic cardiomyopathy (DbCM), which occurs in either Type-1 Diabetes (T1D) or Type-2 Diabetes (T2D),
defines heart failure (HF) that occurs in the absence of coronary artery disease, hypertension, and valvular
disease. Our research has discovered in human myocardial samples and mouse diabetic hearts and
cardiomyocytes (CM) that the transcriptional factor Krüppel-like factor 5 (KLF5) is a central component of DbCM.
We have also revealed mechanisms of KLF5-dependent cardiotoxicity that involve oxidative stress and
lipotoxicity, which combinedly lead to DbCM. Furthermore, we showed that KLF5 upregulation in diabetes is
driven by the transcriptional factor FOXO1. New data identify that FOXO1 cannot stimulate KLF5 expression
unless myocardial glucose is elevated. Moreover, we show that glucose transporter (GLUT)-1 is essential for
cardiac glucose import in both T1D and T2D and leads to DbCM via activation of the FOXO1-KLF5 axis. Based
on our data, we hypothesize that in diabetes, cardiac GLUT1 is the main route for glucose uptake and
leads το DbCM by stimulating both glucotoxicity and lipotoxicity. To address our hypothesis, we propose
the following Aims:
Aim 1: Delineate the signaling events via which GLUT1 leads to DbCM.
Aim 2: Elucidate the cardiotoxic metabolic pathways in DbCM that are controlled by GLUT1.
Aim 3: Explore the therapeutic potential and underlying mechanisms of GLUT1 inhibition for DbCM in T2D.
The proposed study will identify GLUT1 as a new therapeutic target for DbCM and will delineate the signaling
and metabolic pathways that underlie the cardiotoxic effect of GLUT1 in diabetes. Furthermore, we will map the
cardiotoxic pathways that are exclusively dependent on Glucose.

Public health relevance
NARRATIVE Diabetes will affect 10% of the global population by 2040. Heart failure is one of the major complications of diabetes that increase death rate. We discovered that a protein which transfers blood sugar in the heart is critical for heart failure and will now study how this occurs, and how to block it for improving heart function and survival.